Mechanisms of mitophagy in tissue health and homeostasis

Project Summary/Abstract
The long-term goal of our research program is to explore how mitophagy promotes tissue health. Mitochondria
generate cellular energy, and a natural byproduct of executing this essential function is susceptibility to
damage. A wide assortment of human diseases, including metabolic and neurodegenerative diseases, shares
the pathological feature of improper accumulation of damaged mitochondria. Mitophagy, a type of
mitochondrial quality control (MQC), degrades damaged mitochondria to prevent their inappropriate
accumulation; and therefore, represents a critical mechanism required for the maintenance of tissue health.
Most of our understanding of mitophagy comes from research performed in cell lines in culture, and thus, little
is known about how the diverse mechanisms of mitophagy promote tissue health in intact organisms. Our lab
seeks to address this knowledge gap by leveraging the genetic advantages offered by the model organism
Drosophila melanogaster. We previously discovered that disrupting the ataxia-associated gene Vps13D results
in severe perturbations in mitophagy such that mitochondria fated for mitophagy become stalled prior to
degradation. These data have enabled us to elucidate molecular mediators of in vivo mitophagy in the fly,
allowing us to generate unprecedented genetic tools and preliminary hypotheses that will facilitate a better
understanding of the utilization of mitophagy in physiological contexts to support tissue function. In the next five
years, we propose to generate genetic tools to effectively manipulate all known forms of mitophagy in fruit flies
through engineering of the genes required to execute mitophagy: mitophagy adapter and receptor proteins.
With these tools we will test the hypothesis that the two mechanistic forms of mitophagy degrade mitochondria
with functionally distinctive objectives. We will test this hypothesis by individually investigating the physiological
roles of the two forms of mitophagy in flies: ubiquitin-dependent mitophagy (in Research Direction #1) and
receptor-dependent mitophagy (in Research Direction #2). In the third research direction, we will probe the
relationship between these distinct forms of mitophagy to better understand how their interplay maintains
tissue health and homeostasis. Overall, the information generated from this proposal will provide foundational
knowledge on a critical cell biological process closely associated with human disease. In the future, this
knowledge can be used to facilitate the development of mitophagy-targeting therapeutics that have the
potential to treat diseases and conditions associated with mitophagy perturbations such as Parkinson’s
Disease, diabetes, and ischemia-reperfusion injuries.

Public health relevance
Project narrative Dysfunctional mitochondria in a cell represent a hazard; and therefore, require efficient removal to minimize cellular damage. The accumulation of defective mitochondria is proposed to underlie numerous pathological conditions including natural aging, neurodegenerative diseases, metabolic diseases, and cardiovascular diseases. The research in this proposal explores the mechanistic features of the cellular process that neutralizes the threat of amassing damaged mitochondria by targeting them for intracellular degradation; a process known as mitophagy.